THE NIDDK BIOSAMPLE REPOSITORY WILL ALLOW FOR THE CONTINUED RECEIPT AND STORAGE OF BIOSAMPLES FROM MANY DIFFERENT STUDIES, CARRY OUT SPECIFIED SAMPLE PROCESSING AND ANALYSES, AND WIDELY DISTRIBUTE BIO

THE NIDDK BIOSAMPLE REPOSITORY WILL ALLOW FOR THE CONTINUED RECEIPT AND STORAGE OF BIOSAMPLES FROM MANY DIFFERENT STUDIES, CARRY OUT SPECIFIED SAMPLE PROCESSING AND ANALYSES, AND WIDELY DISTRIBUTE BIO